Cancer Questions on the 2025 National Health Interview Survey

The IAA provides funding to support the National Health Interview Survey (NHIS) to collect cancer control data. This project is a collaborative effort between NCHS, NCI and the National Center for Chronic Disease Prevention and Health Promotion (NCCDPHP).